NEUROPSYCHOLOGY OF SENSORY DEVELOPMENT

The objective of this research program is to understand the neurobiological mechanisms underlying the developmental changes associated with early experience. We will test the hypothesis that an increased number and/or size of a particular class of cells mediates the observed structural and functional changes consequent to early experience. We will therefore determine whether the number of cells and/or the size of their dendritic arbors underlies this form of plasticity.